ELUCIDATING MECHANISMS OF THORACIC AORTOPATHY VIA COMPUTATIONAL MODELING

PROJECT SUMMARY
Thoracic aortopathy – aneurysm, dissection, and rupture – is increasingly responsible for morbidity and mortality
in younger (having genetically predisposed lesions) and older (having sporadic lesions) individuals alike, female
and male. Despite many seminal discoveries since 1991, when the genetic basis of Marfan syndrome (MFS)
was uncovered, advances in clinical care have largely remained limited to improvements in surgical methods
and devices as well as better identification of patients who warrant monitoring of aortic diameter until surgery;
patients otherwise continue to be treated with anti-hypertensive medications mainly to reduce hemodynamic
loads on the vulnerable aorta. There is clearly a need for increased understanding. Although such aortopathy
can arise from a predisposing monogenic mutation, we will test the compelling hypothesis that secondary
changes in cell signaling and gene expression represent either potentially protective compensations or further
pathological consequences, and macrophages play key roles in this regard. We submit that, in the absence of
gene editing to correct the predisposing mutation, there is a need to preserve / promote compensatory gene
products while preventing pathological ones. Noting further that hypertension is a key risk factor for aortic
disease, we hypothesize that detailed associations of the transcriptional profile and biomechanical phenotype
will better elucidate mechanisms by which hypertension exacerbates thoracic aortopathy.
Toward this end, we will use consistent methods to quantify the transcriptional profile that drives the bio-
mechanical phenotype of the aorta in 3 mouse models (2 novel) of Marfan syndrome. In this way, we will quantify,
for the first time, specific roles of hypertension as well as two sub-populations of macrophages (resident vs.
recruited) to determine regulatory pathways and cell-cell interactions that superimpose on those associated with
the underlying predisposing mutation and drive changes in aortic structure and function. We submit that
consistent “transcript-to-tissue” level data across these mouse models, as a function of sex as a biological
variable, will provide the large data sets needed to develop 2 new classes of multifidelity, multiscale, data-
informed computational models that will enable unprecedented integrative understanding of molecular, cellular,
and biomechanical mechanisms that drive thoracic aortopathy while providing unique insight into possible new
targets for treatment. This project is significant given the increasing morbidity and mortality associated with
thoracic aortopathy; it is innovative in its consistent quantification of the transcriptionally driven biomechanical
phenotype across diverse mouse models, its use of two new double-mutant mouse models, and its use of novel
advanced (multi-cell, multiscale) computational models to integrate findings across predisposing mutation, cell-
type, and risk factors to delineate protective versus pathologic factors that dictate disease progression.

Public health relevance
PROJECT NARRATIVE Diseases of the aorta are increasingly responsible for significant disability and death in the US. There is a pressing need to identify drivers of disease progression for only in this way can new drug targets be identified. This project is significant for we will, for the first time, develop 2 new computer models to better understand disease progression in 3 key mouse models of aortic disease to gain new insight into underlying cellular mechanisms that drive the disease.